NITRIC OXIDE SYNTHESIS IN BONE MARROW TRANSPLANT PATIENTS

This study will attempt to determine whether or not the elevated nitric oxide systhesis noted in bone marrow transplant patients is mediated by elevalted levels of cytokines. It has been well documented in animal models that induction of the immune/inflammatory nitric oxide synthase (iNOS) is mediated by interferon -gamma (1FN gamma), tumor necrosis factor -alpha and interleukin -1.